Local labor market contexts and substance use in young and middle adulthood: Using agent-based modeling to guide substance use prevention strategies

PROJECT SUMMARY/ABSTRACT:
This K01 Mentored Research Scientist Development Award will provide the candidate, Sehun Oh, PhD., with
protected time and resources to facilitate his transition to research independence in substance use and
prevention research. Although we have been observing disconcerting rates of substance-related problems,
including overdose (OD) deaths, in communities with declining economic opportunities (especially in the
Appalachian and Rust Belt areas), we do not have firm theoretical and empirical evidence to explain how local
labor market contexts may affect substance use (SU) and development of substance use disorder (SUD) and
OD as well as what effective policy interventions might reverse the trends. Building on his interdisciplinary
background in economics, substance use epidemiology, and social policy, the candidate will engage in structured
training and research activities to acquire substantive and methodological expertise to elucidate the role of local
labor market contexts in SU/SUD/OD. Specifically, the proposed career development plan is designed to achieve
three training goals: (1) deepening the candidate’s understanding of local economic contexts (especially the
types and qualities of available jobs) as a key etiology of substance use problems and its socioeconomic,
physical, and behavioral health mechanisms; (2) developing expertise in agent-based modeling and supporting
methods (causal inference and spatial analysis) for local SU/SUD/OD projections; and (3) gain hands-on
experiences in research translation and dissemination to inform prevention policy development. A series of
training activities have been carefully designed, including coursework in epidemiology, public policy,
developmental economics and social work; individualized instruction; mentored training; and research
collaborations over five years. This training also will be achieved by conducting a minimum of three research
studies that address the following aims: (1) elucidating the role of the local labor market (re)structuring in SU/SUD
among individuals in young/middle adulthood, (2) developing agent-based models to make SU/SUD/OD
projections in Ohio until 2030 and to conduct policy experiments to assess the preventive effects of employment
and substance supply-related interventions. To address these aims, the candidate will integrate and analyze
various administrative and survey data (related to local labor market contexts, SU/SUD/OD, and other
environmental characteristics); test the effects of industry-specific job availability (and its changes) and
socioeconomic/physical/behavioral health mediators on SU/SUD/OD; develop agent-based modeling to make
robust projections in Ohio based on local labor market outlook; and conduct simulated experiments to assess
the preventive impacts of employment- and substance supply-related policies using agent-based models. By the
end of the award period, the candidate will be positioned as one of the few investigators in the United States
with the requisite knowledge and skills to use systems science and simulation modeling to inform substance use
prevention policies, especially for communities experiencing economic restructuring and/or contractions.

Public health relevance
NARRATIVE: Substance use, especially in young and middle adulthood, is a major public health problem in the United States, costing more than 100,000 lives and $440 billion annually. This project aims to understand the role of local labor market structure in substance use behaviors and its socio-physical-behavioral health mechanisms, to develop agent-based models to make substance use/use disorder/overdose projections for Ohio through 2030, and to conduct policy experiments. Findings will inform policy interventions to prevent substance use problems, which is especially relevant for areas experiencing economic contractions or employment shocks following a pandemic.